ACCESS-PC: Advancing Care Coordination to Enhance Shared Care for Complex Survivors in Primary Care

PROJECT SUMMARY/ABSTRACT
Cancer survivors with cardiovascular disease risk factors (complex cancer survivors) are a growing population
and their morbidity and mortality risks are significant. Despite strong clinical evidence bases and established
guidelines to manage CVD risks, cancer survivors often forego necessary chronic condition care especially
during cancer treatment. A shared care model (when two or more clinicians of different specialties care for the
same patient) is the optimal care delivery model for complex cancer survivors and has been shown to produce
optimal comorbidity management when primary care is involved. Nevertheless, in the U.S. cancer survivorship
focuses on static approaches such as providing survivorship care plans and guidelines for primary care without
addressing the implementation context and care delivery processes. These approaches have proven insufficient
to shift care paradigms and produce shared care for complex cancer survivors. Many currently proposed and
tested cancer survivorship care strategies are considered oncology-centric and do not align with primary care
generalist orientations in managing patients with multiple chronic conditions or fit in real-world contexts of primary
care practices. Results from our ongoing and recent research studies indicate that survivors managing chronic
conditions should not be disconnected from their primary care team. Therefore, feasibility issues must be
addressed using stakeholder-informed strategies to enhance the translational potential of shared care that aligns
multiple stakeholders (i.e., cancer care team, patients, primary care teams) understandings of this paradigm of
care and build team-based care capacities. This study employs a designing for dissemination, theory guided
perspective, blending implementation science and care delivery conceptual frameworks Exploration, Planning,
Implementation, and Sustainment (EPIS) and Cancer Multi-team System (cMTS) to understand and address the
multi-level factors of implementing shared care in a health system. These perspectives will shape tailoring and
implementation of Primary Care Connect (PC2), a health system intervention designed to align complex cancer
survivors, healthcare team members, and health system implementation actors’ understandings, capacities, and
practices to promote the adoption of shared care delivery models for complex cancer survivors. Using a hybrid
type III effectiveness-implementation study design it aims to: (1) engage diverse primary care and health system
stakeholders to tailor PC2 to maximize implementation strategies fit to the health system and primary care
practice contexts; (2) conduct a randomized controlled trial (n=266 patients) to test the effectiveness of PC2 on
primary care connection, chronic disease management, and patient-reported outcomes; and, (3) evaluate PC2
implementation using a mixed methods approach to inform sustainable usage of the intervention. Study results
are poised to have a profound impact on the adoption of shared care delivery models throughout the U.S. to
optimally mitigate complex cancer survivors CVD risks.

Public health relevance
PUBLIC HEALTH RELEVANCE The number of cancer survivors with cardiovascular risks has increased substantially and CVD mortality has surpassed cancer mortality for many cancer sites. Cancer survivors often become disconnected from their primary care providers during cancer treatment and forego necessary chronic disease care. This study tests health system strategies to improve primary care connection during cancer treatment and has potential to impact implementation strategies used throughout U.S. health systems to reduce cardiovascular risks for cancer survivors.